Next Generation KUH Researchers (GENERATOR) Admin Core

ADMINISTRATIVE CORE - ABSTRACT
The Administrative Core will manage the Mayo Clinic Rochester and University of Wisconsin Next Generation
KUH Researchers ("GENERATOR") Center. It will connect various Center activities, faculty from both
institutions, the CAIRIBU Interactions Core, CAIRIBU Community, Urology Centers Program, NIDDK, Mayo
Clinic, University of Wisconsin administrative structures, and the KUH Research Community.
The Administrative Core will also interact with an External Evaluation Board, whose members’ expertise will
complement the Center administrative and programmatic leadership. The Administrative Core will be
responsible for executing the Center’s communication plan, thereby disseminating our networking and training
programs to undergraduate and graduate students in order to attract the brightest investigators to KUH
research. The Core will also coordinate faculty and trainee interactions via the monthly videoconferences and
annual in person meetings of our center, as well as an annual meeting of all centers. Importantly, the core will
be responsible for monitoring progress of the center including establishing and monitoring milestones. An
important function of the core will be to establish an external evaluation board and coordinate meetings of the
board interaction of the board with center leadership.
Taken together, the Specific Aims of the GENERATOR Administrative Core are to:
AIM 1. Facilitate collaborative leadership of the center.
AIM 2. Develop center milestones and monitor progress including interactions with an external
evaluation board.
AIM 3. Coordinate all virtual and in-person center meetings and coordinate one NIDDK-wide U2C/TL1
Center meeting.
Thus, the Administrative Core will serve as the nexus of the generator Network. This core will coordinate
executive committee activities and interactions with external advisors. The administrative core also coordinates
all meetings and interactions between GENERATOR trainees and faculty including monthly virtual and yearly
in-person meetings.

Public health relevance
The Administrative Core will oversee operations of the Mayo Clinic and University of Wisconsin Next Generation KUH Researchers (“Generator”) U2C Center and serve as the interface between a comprehensive portfolio of Center activities between faculty of the 2 institutions, CAIRIBU, the Urology Centers Program, NIDDK, the Mayo Clinic and University of Wisconsin administrative structures, and the KUH Research Community. The Administrative Core will interact with an External Evaluation Board, Internal Advisory Board, and execute all communications.